Self-Powered In Vivo Joint Load and Angle Sensing in Total Knee Replacement

Project Summary
Total knee arthroplasty (TKA) is one of the most common surgical procedures in all of medicine and despite
technical advances, about 10-20% of patients remain dissatisfied with their outcomes and about 9% of patients
require revision. Leading causes of dissatisfaction and revision include postoperative pain, infection, aseptic
loosening, and instability. Novel technologies, such as 3D surgical planning, patient-specific instrumentation,
and sensor-guided and robotic-assisted arthroplasty, have changed the landscape of modern TKA, yet success
rates have not improved over the past 20 years. Currently, there is no consensus in the arthroplasty community
regarding ideal implant alignment, soft tissue balance, or implant design, and our understanding of aseptic
failure mechanisms in knee arthroplasty is poor. Overall, there is a lack of technology to allow continuous
postoperative in vivo measurement of joint motions and forces, thus precluding advances in knee arthroplasty.
To address this problem, we propose to develop an innovative self-powered smart piezoelectric TKA implant
platform that will enable continuous in vivo measurement of joint kinematics and compartmental joint kinetics,
and allow expandability for future sensors. Our preliminary results demonstrate feasibility of piezoelectric
transducers integrated into knee prosthesis to (a) sense compartmental forces with error <3%, (b) sense
compartmental contact locations with error <1.6 mm, (c) generate around 300 μW of power, and (d) survive at
least 10,000 simulated gait cycles. Our visionary design requires further optimization of the piezoelectric system,
development of a magnetic joint angle sensing system, and pre-clinical evaluation, which is the focus of the
proposed work. Aim 1: we will develop computational finite element models to predict the behavior of smart
piezoelectric TKR force sensors during gait, and develop circuitry for energy harvesting, sensing, and wireless
data transmission. We will experimentally validate the models and circuits via testing of prototypes under
simulated in vitro 6 degree-of-freedom (DOF) joint motion. We will utilize the experimentally-validated models
to optimize the design of the smart piezoelectric implant considering sensing, energy harvesting, and long-term
survivability of the device. We will evaluate the accuracy and reproducibility of final optimized prototypes under
various ADLs, and determine long-term performance over 1 million cycles. Aim 2: we will develop a magnetic
joint flexion angle sensing system by creating computational models and testing prototypes. Magnetic flexion
sensing will be fused with the aforementioned piezoelectric force sensing to resolve all six kinematic DOFs. Aim
3: we will implant our prototype smart knees into cadavers and determine performance over 100 cycles of various
ADLs, and determine ability to sense abnormalities including cement loosening, ligamentous instability,
condylar liftoff, and third-body contamination of the joint surface. The ultimate goal of this research is to fill the
technological gap in postoperative monitoring of TKA to provide the community with valuable data to advance
orthopedic surgical techniques and implant designs to ultimately improve patient satisfaction and human health.

Public health relevance
Project Narrative Total knee arthroplasty (TKA) is one of the most common surgical procedures in all of medicine with projections showing that ~2-2.9 million procedures may be performed annually in the US by 2030, however, about 10-20% of patients are dissatisfied with their outcomes and about 9% of all knee replacements fail, with instability, aseptic loosening, and infection as leading causes. Currently, there is a lack of technology to allow continuous postoperative in vivo measurement of joint motions and forces which precludes advances in our understanding of aseptic failure mechanisms and ideal alignment and soft tissue balance strategies in knee arthroplasty. The purpose of this study is to develop an innovative smart piezoelectric TKA implant platform that will enable continuous and accurate in vivo measurement of joint motions and compartmental joint forces in a completely self-powered manner for the entire life of the implant, with this data being securely and wirelessly transmitted from the smart knee through a base station at the patient’s bedside to medical professionals such as surgeons, physical therapists, implant designers, and researchers, with the overarching goal of advancing orthopedic surgical techniques and implant designs to ultimately improve patient satisfaction and human health.